ATP1B3: novel regulator of T cell-mediated immunity

Project Summary
T cells are key components of immune responses to infection and in autoimmunity. Like all cells, they require
ion channels and transporters for their function. Channels move ions such as calcium, sodium and potassium
across lipid membranes to maintain ion gradients, facilitate signal transduction and influence many cellular
processes. Several channels are known to play critical roles in immune cells. In general, however, only a small
number of the known hundreds of channels have been studied in T cells. This is a major gap in our
understanding of T cell biology and the mechanisms underlying T cell-mediated immune responses. From a
clinical perspective, ion channels are excellent drug targets as is evident from the fact that many channel
blockers are used for the treatment of cardiovascular and neuropsychiatric disorders. There are currently no
FDA-approved drugs targeting ion channels for the treatment of autoimmune and inflammatory diseases. To
address this gap in knowledge and missed opportunity for drug discovery, we conducted functional genetics
screens to identify hitherto unrecognized ion channels that control T cell function in the context of infection and
autoimmunity. Some of the strongest and least understood channel-related genes to emerge from these
screens were components of the sodium-potassium ATPase. This multiprotein complex is located in the cell
membrane and uses ATP as energy source to pump sodium ions out of cells in exchange for potassium ions
that go in. In neurons, this complex is essential for electrical excitability and in the heart for the ability of muscle
fibers to contract. In T cells, by contrast, the function of the sodium-potassium ATPase and its role in immune
responses to infection and autoimmunity are almost completely unknown. We identified four subunits of the
sodium-potassium ATPase in our screens and confirmed that two of them in particular are required for the
antigen-driven expansion of T cells in vivo. This expansion of T cells during infection or in autoimmune
diseases is an essential hallmark of adaptive immunity. Our data show that deletion of ATP1B3, one of the
subunits of the sodium-potassium ATPase we identified, almost completely suppresses T cell expansion and
disease in a preclinical model of multiple sclerosis, an autoimmune disease in which T cells promote
inflammation and destruction of the brain. Additional data generated by using unbiased transcriptomic and
metabolomics approaches point to a role of ATP1B3 and the sodium-potassium ATPase in regulating the cell
cycle and metabolism of T cells. In this proposal, we will determine how ATP1B3 regulates the function of the
sodium-potassium ATPase in T cells, investigate the signaling and metabolic mechanisms by which ATP1B3
controls T cell function, and determine how ATP1B3 regulates T cell-mediated immune responses and its
suitability as a drug target in autoimmunity.

Public health relevance
Project Narrative Immune responses to infection depend on the proper function and expansion of antigen-specific T cells, a process that can go awry when T cells recognize auto-antigens and cause autoimmunity in diseases such as multiple sclerosis. The function of T cells is dependent on the activity of channels in the cell membrane that transport charged ions in and out of cells, and we identified a subunit of the sodium/potassium ATPase as an important new regulator of T cell function. In this proposal, we will determine the molecular function of a sodium/potassium ATPase subunit in T cells and its role in autoimmune inflammation in a preclinical model of multiple sclerosis, which is essential to assess the suitability of this sodium/potassium ATPase subunit as a drug target.